Alveolar Epithelial Stress Signaling in Lung Fibrosis

ABSTRACT
Pulmonary fibrosis (PF) is a devastating and progressive lung disease with a rising incidence and prevalence
and minimally effective therapies. PF pathology is characterized by aberrant mesenchymal and epithelial
populations that disrupt the normal alveolar lung architecture. In the alveolar epithelium in human PF and murine
PF models, a subset of Alveolar Type 2 (AT2) cells lose their quintessential transcriptional program, entering but
failing to exit an “aberrant transitional” state between AT2 and Alveolar Type 1 (AT1) cells. These cells are found
in proximity to pathological collagen producing fibroblasts and they are transcriptionally enriched in fibrotic
mediators, suggesting they may pathogenically activate alveolar fibroblasts. Why these aberrant transitional
AT2s arise, why they fail to differentiate to AT1s, and how they contribute to fibrosis is not understood. We have
identified that the aberrant transitional AT2s are enriched in the PKR-like ER kinase (PERK) cell stress pathway
and its downstream Integrated Stress Response (ISR). How PERK-ISR signaling relates to the emergence and
persistence of the aberrant AT2s and to the epithelial contribution to fibrogenesis is also not known. In this
proposal we will answer these questions by utilizing complimentary in vivo models of lung fibrosis with a human
model system. For our murine models, we use mice that express a human PF-associated mutation in the AT2
restricted Surfactant Protein C gene (SftpcMut mice) where intrinsic AT2 stress pathways initiate spontaneous
lung fibrosis without a “second hit” lung injury and the established Bleomycin (Bleo) fibrosis model of extrinsic
AT2 activation and lung fibrosis. Our human system is an induced pluripotent stem cell (iPSC)-based AT2 (iAT2s)
model from a PF patient harboring a SFTPCMut. In both murine models we have found that AT2s are enriched in
PERK-ISR signaling as they enter and persist in the aberrant transitional state. We have developed a strategy
to sort the most fibrogenic aberrant transitional AT2s from the mouse lung and found that in ex vivo co-culture
systems these cells induce a fibrotic response in alveolar fibroblasts. We also discovered that SFTPCMut iAT2s
develop an aberrant transitional gene signature and are enriched in PERK-ISR signaling and profibrotic
mediators. We will now test our hypothesis that PERK-ISR signaling promotes AT2s to enter and restrains their
exit from an aberrant transitional state that contributes to lung fibrosis by pathogenically activating alveolar
fibroblasts. We will [Specific Aim 1] determine how aberrant transitional epithelial cells directly contribute to
fibrosis and test our hypothesis that an altered alveolar niche signaling circuit initiated by the aberrant transitional
epithelial cells promotes fibrotic tissue remodeling. We will [Specific Aim 2] define how PERK-ISR signaling
impacts epithelial differentiation and promotes fibrosis and test our hypothesis that PERK-ISR signaling
contributes to AT2 persistence in the aberrant transitional state. When completed these studies will fill critical
knowledge gaps in PF biology by defining the direct contribution of the aberrant transitional cell to fibrosis and
the mechanistic impact of the targetable PERK-ISR pathway in PF pathogenesis.

Public health relevance
NARRATIVE Pulmonary Fibrosis (PF) is a chronic progressive lung disease that results in respiratory failure due to disruption of normal lung architecture and function from aberrant epithelial and fibroblast cells in the lung alveolus. In this proposal we will couple multiple murine fibrosis models with PF patient-derived cell modeling to identify why an anomalous population of alveolar epithelial cells observed in human PF and murine models of PF arises and how these cells cause pathological activation of fibroblasts and subsequent PF pathology. This study will thus fill critical knowledge gaps in PF biology and mechanistically interrogate targetable pathways in PF pathogenesis.